Highly multiplexed tissue imaging with high-plex in situ signal amplification

Project Summary
The identity and spatial context of biomolecules (e.g., protein and RNA) in cancer cells are crucial components
of their pathology. Therefore, a scalable and multiplexed imaging platform that can simultaneously map the
protein and RNA landscapes tissue would be a vital tool towards deeply profiling and mapping cancer cell types
in their spatial context. Extensive efforts have been made toward this end to reveal unprecedented details at
both cellular level and molecular level. However, these methods generally lack high multiplexity or suffer low
sensitivity as the target abundance decreases. In addition, highly multiplexed methods for co-imaging of protein
and RNA at the whole tissue level still lag behind. We here aim to address these limitations by developing a
versatile imaging platform for highly multiplexed, rapid, scalable proteomic and transcriptomic mapping of cell
line and mammalian tissue samples with high-plex signal amplification. We propose to (Aim 1) develop a simple,
highly controllable polymerase mediated iterative in situ DNA extension (ISE) and concatenation. We will
demonstrate the application of ISE on the imaging of protein and RNA targets in both tissue and cell sample with
high signal-to-noise and signal specificity. We will also (Aim 2) validate the scalability of ISE imaging in cell and
tissue samples. We will optimize the technology to achieve spatial mapping of 50 to 100-plex protein and RNA
targets in mammalian tissue samples. Finally, we will (Aim 3) validate ISE imaging in both FFPE and thick tissue,
both normal and cancerous sample types. We will co-detect both RNA and protein tumor biomarkers in clinical
FFPE samples and finally, we will integrate the ISE imaging methods with existing tissue clearing methods
(iDISCO, CLARITY, etc.) to enable high-throughput and highly multiplexed tissue imaging from cellular level to
molecular level for both normal and cancerous brain tissue. We will establish a platform for 50-plex imaging in
hundreds micrometer to millimeter thick mammalian tissue specimens to unveil unprecedented detail in the
tissue. The proposed work will deliver a comprehensive imaging toolset including a low-cost, simple design of
orthogonal DNA probes for multiplexing imaging on protein and RNA molecules, and a scalable signal
amplification method for multiplexed fluorescence imaging in different types of tissues. We envision that our
technologies will be widely accessible and seamlessly incorporated into the pipelines, workflows, and coordinate
frameworks of the mission for clinical researchers, pathologists, as well as the wider bio-imaging community to
facilitate cancer research and clinical practice.

Public health relevance
Project Narrative Mapping the key molecular building blocks (RNA and protein) of cancer cells in their spatial context in tissue is crucial to depict the significant components that drive biological function and pathology. We propose to develop a scalable imaging platform for highly multiplexed, rapid, visualization of protein and RNA in large volume tissue samples at both cellular and molecular level.